Enhancing endoplasmic reticulum stress in ovarian cancer

Project Summary/Abstract
Ovarian cancer (OCa) is the deadliest of all gynecologic cancers in the United States. Despite initial response to
chemotherapy, most OCa patients become resistant and progress to metastatic disease. Long-term prognosis of
OCa is dismal, and new therapeutic strategies are desperately needed to improve OCa patient survival. The rapidly
proliferative OCa cells have a high demand for de novo protein synthesis, which results in an enhanced basal level
of endoplasmic reticulum (ER) stress. Indeed ER-stress associated proteins GRP78, PERK, and ATF6 are
overexpressed in OCa compared to normal tissues. ER stress triggers the compensatory unfolded protein response
(UPR), which can either restore homeostasis or activate cell death. We reasoned that the high basal level of ER
stress in OCa represents a critical vulnerability, and drugs that further aggravate this already engaged system in
OCa may exhaust its protective features and contribute to apoptosis induction. Towards that end, we have identified
a first-in-class compound, the oligobenzamide ERX-208, which enhances ER stress in OCa cells but not in
primary epithelial cells. ERX-208 significantly reduced the growth of OCa xenografts, patient-derived explant, and
patient-derived xenografts. Unbiased CRISPR knockdown screens identified the lysosomal acid lipase A (LIPA)
protein as the critical target of ERX-208: knockdown of LIPA abrogates response to ERX-208, while reconstitution
of LIPA restores ERX-208 response. We have shown that the binding of LIPA to ERX-208 is critical for the ability
of ERX-208 to induce ERS and subsequently apoptosis in OCa cells. The objective of this proposal is to conduct
mechanistic studies to identify the precise mechanism of action of ERX-208 in OCa, to optimize the “lead” ERX-
208 analog with improved pharmacologic and pharmacokinetic features and to validate that ERX-208 can
overcome the heterogeneity of OCa. Our overarching hypothesis is that the binding of ERX-208 to LIPA
enhances ERS and induces apoptosis in OCa and targets a critical vulnerability in OCa. Aim1 studies will establish
molecular correlates of ERX-208 in OCa cells using unbiased transcriptomics and proteomics, define
ultrastructurally how ERX-208 binding to LIPA causes ERS/UPR, define specific interactions between ERX-208
and LIPA with unbiased mutagenesis and define LIPA binding partners disrupted by ERX-208 and their effect on
ERS/UPR pathways. Aim 2 studies will use medicinal chemistry approaches to generate few ERX-208 analogs for
enhanced specificity for LIPA, define the maximum tolerated dose, dose-ranging studies for ERX-208, and
determine PK, PD, and toxicity to therapeutic ratios. Aim 3 studies will test the efficacy of ERX-208 in blocking
OCa progression in vivo using clinically relevant orthotopic xenograft, syngeneic mouse models, patient-derived
explant, organoids and patient-derived xenograft models. We believe that our studies will establish a novel
therapeutic strategy (enhancing ERS), novel therapeutic target (LIPA), novel therapeutic agents (ERX-
208/analogs) and the preclinical rationale for further clinical translation for patients with advanced OCa.

Public health relevance
Project Narrative Ovarian cancer (OCa) is the deadliest of all gynecologic cancers, and new therapeutic strategies are desperately needed to improve OCa patient survival. We identified a small chemical molecule ERX-208, that promote endoplasmic reticulum (ER) stress in OCa cells but not in normal cells and has potent anti-proliferative activity. Proposed studies will enable both a better molecular understanding of how ERX-208 induces ER stress in OCa cells and enable rational design of more potent versions of ERX-208 either alone in combination with current chemotherapies. We believe that this project will generate a novel therapeutic agent and the preclinical rationale for further clinical translation.